EVALUATION OF LIVE ATTENUATED ROTAVIRUS VACCINES

Rotaviruses are the single most important etiologic agents of severe diarrhea in infants and young children in developing countries. In developed countries rotaviruses are responsible for one-third to one-half of the hospitalization of infants and young children for diarrheal illness. In developing countries, where diarrheal diseases are responsible for 5-10 million deaths per year in infants and young children, rotaviruses are characteristically the major cause of severe diarrhea in this age group. Thus, the need for a rotavirus vaccine is clear. The goal of such a vaccine is to prevent severe rotavirus diarrhea during the first 2 years of life when the disease is most serious. We have characterized and evaluated an animal rotavirus, the rhesus rotavirus (RRV) strain MMU18006, as a vaccine candidate. RRV has not been recovered under natural conditions from infants or children and thus does not appear to be a virus of the human heritage. In addition, the genes of RRV exhibit significant divergence in sequence from the corresponding genes of the known human rotavirus serotypes. Nonetheless, this virus is similar to human rotavirus type 3 in its neutralization specificity. Furthermore RRV grows efficiently in a semi-continuous line of diploid cells, DBS-FRhL-2. This is an important property because adventitious agents often contaminate primary monkey kidney cell cultures. In addition, RRV can serve as a parent for construction of rotavirus reassortants possessing the major neutralization protein (VP7) of one of the other 3 human rotavirus serotypes. Such reassortants will be needed in a multivalent vaccine since the RRV failed to provide broad protection against other human rotavirus serotypes in the very young infant group.